Enhanced Safety and Health Training for Western Mine Workers

Project Summary/Abstract
The Colorado School of Mines (CSM) Energy, Mining and Construction Industry Safety Program
(EMCIS) is a well-established training organization that was initially formed in 1999 as the CSM
Mine Safety and Health Program. With mining still at its core, CSM operates its training center
to enhance the quality and availability of health and safety training for Western mine workers.
Goals include providing workers with relevant knowledge regarding hazards associated with
working on mine sites and effective controls for reducing risk for injuries and illnesses. In
addition, trainees will be continuously encouraged to be active participants in improving the
health and safety conditions where they work. CSM proposes to offer a comprehensive
approach to meet the safety and health training needs of the Western mining industry by
providing a high quality, interactive training experience that targets several audiences: mine
workers, trainers, safety and health professionals, mine management, and mining engineering
and geology students. In addition, CSM’s training program will service underrepresented
industry sectors such as contractors, consultants, suppliers and equipment manufacturers.
Courses will be taught by highly qualified, professional instructors, who are technical experts as
demonstrated by academic degrees, professional certifications and licenses, and experience.
Depending on the training activity, CSM will utilize a combination of teaching pedagogies,
including classroom discussion, hands-on exercises, games and group activities, and
participation at the Edgar Underground Mine, as well as opportunities for online delivery, for
these courses which will enhance student engagement, understanding, and knowledge
retention. The NORA sector that will be addressed by CSM is the Mining Sector. Primary NORA
cross-sectors of Hearing Loss Prevention, Respiratory Health, Traumatic Injury Prevention, and
Healthy Work Design and Well-Being are addressed indirectly by being included as topics in
various training courses offered to the mining industry.

Public health relevance
Project Narrative The Colorado School of Mines (CSM) Energy, Mining and Construction Industry Safety (EMCIS) program will provide a comprehensive approach intended to meet the safety and health training needs of the Western mining industry by providing a high quality, interactive training experience that targets mine workers and underserved audiences throughout the Western states, including safety and health professionals, mine management and supervision, contractors, consultants, suppliers, equipment manufacturers, and academia (faculty, staff and students). Through the training and educational activities offered by CSM, trainees will be exposed to critical concepts using best industry practices and adult learning techniques to facilitate the development and retention of fundamental skillsets essential to advancing safe and healthy work practices and the ability to identify and eliminate hazards. Future benefits of these efforts are to provide mine workers with the core values and knowledge necessary for positive, life-long improvements to the mining industry, as well as proactive practices and tools vital for reducing the risk associated with injuries and illnesses.